Human Microbiome and its Role in the Development of Lumbar Spine Degeneration and Modic Changes

Summary
Chronic low back pain (LBP) is the world’s most disabling condition, whose management
outcomes are often unsatisfactory and health-care costs worldwide are astronomical. Modic
changes Type 1 (MC1: subchondral bone marrow lesions adjacent to the endplate that are
associated with inflammation) on magnetic resonance imaging (MRI) are highly associated with
the development and severity of chronic LBP. The etiology of MC1 remains speculative.
Systemic inflammatory and metabolomic biomarkers have been associated with MCI; however,
still under scrutiny. Intervertebral disc degeneration (DD) in general has been associated with
bacterial invasion, but not replicated and questionable. The human microbiome has been
associated with a string of human diseases. The following proposal aims to identify if lumbar
MC1 are associated with the pro-inflammatory nature of the intestinal microbiome compared to
non-MC1 intervertebral discs. Integrative approaches taking into account the microbiome,
metabolomics and systemic inflammatory markers will also be addressed in relation to MCI of the
lumbar spine.

Public health relevance
Project Narrative Findings from this study will be the world’s first initiative addressing, via an integrative microbiome-metabolomic-systemic inflammation approach, the structure of the microbiome in intervertebral disc with Modic changes (in comparison to control discs with non-Modic changes) of the lumbar spine in spine surgery patients. Disc material, blood, skin and gut microbiota will be assessed. Findings from this study may introduce new understanding of the etiology of spine disease and pain that can lead to the development of novel personalized, targeted therapeutics.